Glutamine Starvation as a Means to Enhance Antibiotic Efficacy against M. tuberculosis

Project Summary
Mycobacterium tuberculosis (Mtb) is a public health threat responsible for nearly 2 million deaths annually. While
an efficacious chemotherapeutic regimen exists, infection relapse is common even after an extensive treatment
time (6-9 months). Recent evidence indicates that Mtb antibiotic tolerance directly impacts treatment times and
opens the window for the selection of antibiotic resistance in persistent bacterial populations. Multiple studies
have shown that heterogeneously expressed immune pressures such as reactive nitrogen species induce
antibiotic tolerance in Mtb sub-populations. Therefore, one strategy to improve antibiotic efficacy is to target
pathways that reduce Mtb antibiotic tolerance in the face of immune insult. Data from the Sassetti lab and others
indicated that loss of Mtb glutamine (Gln) import or synthesis reduces bacterial viability and antibiotic tolerance
during murine infection. Based on these findings, the hypothesis of this proposal is that Gln starvation leaves
Mtb vulnerable to host immune pressures which translates as reduced antibiotic tolerance and increased drug
efficacy in vivo. Therefore, this proposal seeks to understand the mechanistic link between Gln starvation,
immune pressure vulnerability, and reduced antibiotic tolerance. To do this, the experiments described will use
Mtb strains deficient for Gln synthesis and/or host Gln import as a means to induce Mtb Gln starvation and disrupt
Gln metabolism. These strains will be used to assess how Gln starvation impacts antibiotic efficacy during murine
and intracellular infection. Aim 1 of this proposal will use single cell RNAseq to probe Mtb heterogeneity during
murine infection and treatment. Aim 2 will explore the mechanistic links between immune pressures such as
reactive oxygen species (ROS), reactive nitrogen intermediates (RNI), phagosome acidification, Gln restriction
and Mtb antibiotic tolerance using engineered macrophage cell lines. Finally, as a proof of concept, Aim 3 will
use the relapsing mouse model to assess the impact Gln starvation has on infection clearance and relapse
following an extended antibiotic treatment. The PIs assert that the data generated in this proposal will pave the
way for new therapeutic strategies that both directly target Mtb viability and disrupt antibiotic tolerance leading
to a more efficacious therapeutic regimen. The research plan proposed will act as a means to expand on the
trainee’s skill set with a new emphasis on host-pathogen interactions. The techniques proposed include novel
host and bacterial genetic approaches, high content murine immune profiling coupled with infected cell sorting,
and evaluation of antibiotic efficacy in multiple animal models. The training environment described in this
proposal provides the trainee with opportunities to train under senior researchers with expertise in host and
bacterial genetics, high throughput cell profiling, and high content sequencing analysis. The completion of this
proposal will establish the trainee in methods with techniques to become an independent scientist.

Public health relevance
Project Narrative: Nearly 1 in 3 people are infected with M. tuberculosis worldwide and roughly 2 million people die annually from TB. Evidence has shown that Mtb metabolism is linked to Mtb immune and antibiotic tolerance. This proposal seeks to ascertain how glutamine starvation and metabolic disruption impacts Mtb antibiotic tolerance during infection.